Request for Hysitron TI950 TriboIndenter Nanoindenter with Raman Spectroscopy

This proposal is for the purchase of a Hysitron TI950 TriboIndenter/Raman Spectroscopy System, which will add nanoscale materials science capabilities (e.g., nanoindentation, nanofabrication) and high resolution Raman Spectroscopy capabilities (e.g., chemical composition, mineral/crystal isoforms) to our present instrumentation—providing a significant improvement in our ability to measure physical and chemical properties of organs, tissues, cells, compounds, implants, and engineered materials. The laboratories interested in this piece of equipment are involved in a wide range of funded research programs, including bone metabolism, orthopaedics, cancer biology, diabetes, and obesity. With the Hysitron TI950 system, we will be able to measure true material properties of mineralized and soft tissues directly, without the need to estimate parameters based on macro-level tests that have flawed translation to the nano-scale. In addition, the particular instrument we are requesting has the capability to collect Raman spectra and nanoindentation-derived mechanical properties from the same micro-moeity, which will significantly improve the quality of experiments and measurements that we take, and at the same time, will usher in a multitude of new lines of investigation and collaboration that we currently do not enjoy. There are numerous VA-funded investigators at the Indianapolis VA that would benefit greatly from acquisition of the Hysitron TI950 system, including Drs. Robling (osteoporosis/mechano- transduction), Allen (osteoporosis/anti-resorptives), Moe (chronic kidney disease), Bellido (osteoporosis/hormone signaling), Roodman (multiple myeloma), Nakshatri (sarcopenia/cachexia), Chirgwin (myeloma/osteocytes), and March (adipose-derived stem cells). Moreover, the system would allow each of these VA investigators to expand their research programs and begin initiating new collaborations with the large biomedical engineering community on the IU Indianapolis campus, who have expressed significant interest in the system.

Public health relevance
Veterans suffer from a variety of health complications, including osteoporosis, cancer, diabetes, obesity, and chronic kidney disease. In order to develop the next generation of treatments and therapies for those conditions, cutting-edge basic science research is required. The research team at the Roudebush VA Medical Center is dedicated to discovering new and improved treatments for those conditions, but technical instrumentation/capability is lacking. The long-term objective of this proposal is to acquire a new instrument that will assist Roudebush VA scientists and physicians in their research programs, with the ultimate goal of discovering better and more efficacious options for treating veterans that suffer from osteoporosis, cancer, diabetes, kidney disease, and other chronic conditions that might be a focus area in the coming years. Acquisition of the Hysitron TI950 TriboIndenter/Raman Spectroscopy System, described in this proposal, would significantly improve the research capabilities and productivity in all the target areas mentioned.